Mechanisms and pathways of trans-tight junction conductance

DESCRIPTION (provided by applicant): Intestinal barrier function is reduced in inflammatory bowel disease (IBD) and other intestinal disorders. Alterations of tight junctions, which form the major paracellular barrier, contribute to barrier loss by allowing increased paracellular flux of ions and molecules. Published reports and my preliminary data, which assess the role of different inflammatory cytokines in the lamina propria of IBD patients, support the hypothesis that at least two mechanisms of tight junction barrier regulation are activated by inflammatory cytokines. TNF induces tight junction dysfunction via a mechanism involving occludin internalization that alters tight junction size selectivity and permits increased macromolecular flux. In contrast IL-13 activates a functionally distinct pathway involving expression of claudin proteins that affects ion selectivity but does not increase macromolecular flux. Despite advances in understanding the processes involved in cytokine-induced barrier regulation, the molecular events that define size- or ion-selective changes are unclear. This, in part, represents the technical obstacle posed by traditional time and spatially averaged measurements of barrier function. I hypothesize that the tight junction barrier is highly dynamic at the local, sub-micron level, and that regulation of paracellular flux occurs through modulation of opening and closing events involving more than one class of tight junction pore or other conductance pathway. Because the tight junction spans two cells, it has not been amenable to molecular and biophysical analyses and development of specific pharmacologic modulators, such as those that exist for transmembrane ion channels. In order to eliminate this gap in available methods and molecular understanding, I have developed a novel approach to analyze tight junction barrier function at the local sub-micron level, using a high resolution single electrode patch clamp technique. While this approach is extensively used in the study of transmembrane ion channels and transporters, it has not been applied to the study of tight junction function. My preliminary recordings using this approach show previously unrecognized barrier dynamics, and I hypothesize that this behavior underlies normal tight junction function as a selectively-permeable barrier and is also necessary for understanding the molecular mechanisms and basis for multiple pathways of barrier dysfunction in disease. These local measurements will be performed alongside traditional assays of tight junction function (Aim 1) to study tight junction dynamics at steady state (Aim 2) and after exposure to inflammatory cytokines IL-13 and TNF (Aim 3). The data will have significant positive effects on human health by improving the understanding of barrier function and dysfunction, which may provide better therapeutic approaches for intestinal disorders such as IBD, celiac disease, and infectious colitis. Furthermore, both the knowledge gained and the technical approaches developed will be easily adapted to the study of tight junctions in other organs, including integument, central nervous system, vasculature, lung, kidney, and skin, and, therefore, may have broad impact beyond gastrointestinal disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Narrative Intestinal barrier function is reduced in inflammatory bowel disease and other intestinal disorders. Alterations of tight junctions, which form the major paracellular barrier, contribute to barrier loss by allowing increased paracellular flux of ions and molecules. Barrier dysfunction involves separate mechanisms for ionic and macromolecular flux, but the molecular basis for these different pathways is unclear. The research outlined will study these mechanisms using high resolution patch clamp recordings of tight junction barrier dynamics. Narrative Intestinal barrier function is reduced in inflammatory bowel disease and other intestinal disorders. Alterations of tight junctions, which form the major paracellular barrier, contribute to barrier loss by allowing increased paracellular flux of ions and molecules. Barrier dysfunction involves separate mechanisms for ionic and macromolecular flux, but the molecular basis for these different pathways is unclear. The research outlined will study these mechanisms using high resolution patch clamp recordings of tight junction barrier dynamics. __SpecificAimsTextDelimiter__ 10. Specific Aims Inflammatory bowel disease (IBD) affects approximately 1.4 million Americans and is responsible for significant lifetime morbidity, including diarrhea and extensive nutrient and protein loss. These symptoms are partly explained by alterations of tight junctions, which are the major barrier to paracellular flux of ions and small molecules across an intact intestinal epithelium. Different lamina propria inflammatory cytokines, including tumor necrosis factor (TNF) and interleukin-13 (IL-13), can contribute to tight junction barrier dysfunction (26-28), and both published reports and my own strong preliminary data indicate that these cytokines induce barrier dysfunction by more than one mechanism. My data also show that IL-13-induced alterations of claudin proteins affect tight junction ion selectivity, while TNF modulates the cytoskeleton to trigger occludin internalization and alters macromolecular size selectivity (Fig 1). The underlying molecular mechanisms by which these events affect barrier function are poorly understood, in part because widely used methods involve time and spatially averaged measurements of global barrier function and do not measure local function at the sub-micron level. This knowledge gap limits both structural and functional analyses and has been an obstacle to development of specific pharmacologic modulators, such as those that exist for transmembrane ion channels. My long term goal is to understand how altered tight junction function at the microscopic (sub-micron level) contributes to epithelial pathophysiology. The objectives of this application, which are essential to my long term goal, are to understand the biophysical characteristics that define tight junction barrier function under normal conditions and after exposure to inflammatory cytokines and to elucidate the processes responsible for cytokine-induced barrier modulation. My central hypothesis is that the tight junction barrier is highly dynamic, and that regulation of paracellular flux occurs through modulation of molecular "events" involving more than one class of tight junction pore or other conductance pathways with different size and charge selectivities. These events may represent 1) opening and closing events in the classic "ion channel" sense, 2) reorganization of proteins within the tight junction and/or 3) transient tight junction breaks or separations of tight junction strands between adjacent cells. This hypothesis is supported by my preliminary data showing previously unrecognized dynamics of barrier function using local patch clamp techniques to measure from small tight junction segments. I am particularly well qualified to perform these studies, given my background in electrophysiology and expertise as a gastrointestinal pathologist, and have established a strong supportive environment. My training plan will focus on developing skills as an independent investigator while accomplishing the following specific aims: Specific Aim 1: To determine the effects of cytokines on global barrier function Fig. 1. Pathways of tight junction function a. To determine the effects of TNF and IL-13 on global tight junction ion selectivity b. To determine the effects of TNF and IL-13 on global tight junction size selectivity c. To define roles of ZO-1, occludin, and claudins on cytokine-induced global barrier changes Specific Aim 2: To define the steady state tight junction barrier at the sub-micron level a. To measure tight junction dynamics using local tight junction patch clamp recordings b. To define the role of myosin light chain kinase and the perijunctional actomyosin ring in local, sub-micron tight junction barrier dynamics c. To determine the roles of ZO-1, occludin, and claudins in local tight junction dynamics Specific Aim 3: To define influence of cytokines on the sub-micron tight junction barrier a. To characterize TNF and IL-13-induced changes in local tight junction barrier dynamics b. To define the role of myosin light chain kinase in cytokine-induced changes in local barrier dynamics c. To define the roles of ZO-1, occludin, and claudins in cytokine-induced changes in local barrier dynamics This research is innovative because it takes advantage of and develops a new approach to assess local tight junction function using single electrode voltage clamp techniques. These local measurements will be performed alongside traditional, well-validated methods (Aim 1). The data will help to define the role of tight junction dynamics in barrier function at steady state (Aim 2) and determine how the barrier is perturbed by inflammatory cytokines (Aim 3). My findings will have significant positive effects on human health by improving understanding of barrier function and dysfunction, which are necessary for development of therapies to correct barrier function and, potentially, treat disorders including IBD, celiac disease, and infectious colitis.